Enrichment Program

Enrichment Program Abstract
The Enrichment Program of the George M. O'Brien Kidney Center at Yale provides a gateway for educational
training in modern methods of kidney research for medical students to principal investigators. Funding is
requested for such activities as our yearly state-of-the-art symposium held at Yale University. This event attracts
world leaders to share their extensive knowledge resulting in the further exchange of ideas that may lead to
fruitful collaborations. Furthermore, this program will provide training for undergraduate, medical students, and
renal fellows, with an overall goal for these trainees to pursue either a laboratory or patient-oriented investigative
career in kidney research.